Development of a Photo-cleavable Agent for Reversible Protein Dimerization

DESCRIPTION (provided by applicant): This proposal seeks to develop a novel method for controlling the activity of engineered proteins within cells. The use of chemical dimerizing agents such as rapalog have been very valuable as a means of activating cell surface receptors or disabling proteins in a cell by crosslinking them. We seek to create a Chemically-Induced Dimerization agent (CID) that is cleaved by light, thereby making the dimerization rapidly reversible. Such a molecule needs to lack endogenous binding partners in cells, be readily membrane permeant, have no toxic side effects, and be efficiently cleaved by light of a wavelength that will not cause cellular damage or interfere with standard imaging methods. We propose to characterize a candidate photocleavable CID to determine its kinetics and concentration dependence and thereby validate its suitability for work in cells in culture. We propose methods to optimize its affinity and efficacy, and we propose to test the reagent in a split kinesin assay of axonal transport to determine if it can be used to rapidly uncouple a cargo from its anterograde motor in a live neuron.

Public health relevance
PUBLIC HEALTH RELEVANCE: Inactivating a particular protein has been a major means of probing its functional importance in the nervous system. Classical means of doing so include the use of mutants, RNAi, or blocking drugs but these methods have their drawbacks. Mutants may have early developmental defects and RNAi can only slowly bring about the depletion of a protein from a cell. For many proteins, no drugs are available to selectively inhibit them. We are proposing to develop and validate a chemical method to selectively activate or inhibit a protein. It uses a dimerizing agent that can either 1) hold two halves of a protein together or 2) tie one protein to another. This dimerizing agent is designed to be lysed by illumination at 405 nm so that the protein state can be rapidly changed.